NIDCD Temporal Bone Resource

PROJECT ABSTRACT
The ability to collect and share data is critical to advances in clinical care and improved healthcare. While general collections of data associated with genes, proteins, and other types of assays are available and essential, specialized domains require more focused data repositories to adequately represent the unique aspects of the research domain. This is especially true of data related to deafness and communication disorders. The study of the causes and treatment of these conditions often requires unique combinations and types of data. With this in mind, we propose to create a unique shared data repository, specifically targeted toward the research projects funded by the National Institute for Deafness and Communication Disorders. In order to achieve rapid deployment and operational efficiency, we will build on the highly successful FaceBase data-sharing infrastructure. Specifically, we propose to provide the necessary infrastructure, services, and processes for data migration, data collection, handling of PII/PHI, dissemination, and data stewardship for the NIDCD Temporal Bone Database and related data resources. The team will consist of software engineering, data engineering, website design and development, and technical leadership throughout the period of performance. During the first year, the team will prioritize the migration of data from existing database(s), including data that may initially contain PII/PHI, into the FaceBase infrastructure and establish a web-based portal for access (search, uploads, downloads).

Public health relevance
PROJECT NARRATIVE The major goal of this project is to create a new data-sharing resource to support research projects funded by the National Institute for Deafness and Communications Disorders. A core activity will be to rehost the Temporal Bone Database onto the technology platform that is consistent with the FaceBase data repository.